2022 Teaching Kitchen Research Conference

This R-13 Grant application requests support for the 3rd conference entitled 2022 Teaching Kitchen
Research Conference (2022 TKRC) to be held at University of California, Los Angeles Meyer and Renee
Luskin Conference Center on October 18-19, 2022. This conference will, once again, be sponsored by the
Harvard T.H. Chan School of Public Health (Harvard Chan) Department of Nutrition in association with the
Teaching Kitchen Collaborative, Inc. (TKC). The inaugural 2018 TKC Research Day, as well as the 2nd 2020
2020 TKRC, were co-funded through R13 grants from NCCIH (Grant#1R13AT009822-01, #1R13AT010554-
01). Both conferences were successful, with 2,572 registrants from 75 countries participating in the recent
2020 TKRC which was presented virtually (due to COVID prohibitions).
As evidenced by the increase in registrants between the 2018 and 2020 conferences, this growing field is of
high interest to the medical, scientific, corporate and public health communities due to its interdisciplinary
nature and its potential to address the needs of a range of patient populations with enhanced risk of chronic
disease and the potential for teaching kitchens to address challenges relating to food insecurity and racial
health disparities. Additionally, the COVID-19 pandemic required teaching kitchen programs to create novel,
virtual, interactive programming opportunities, thereby extending the potential for these programs to impact
behaviors and outcomes of far greater numbers of trainees across a range of populations and venues. The fact
that more than 900 registrants from the 2020 TKRC reported their home institution had already built, or would
build a teaching kitchen, suggests the research in this area will increase over the coming decade.
The 2022 TKRC will be directed by an Organizing Committee which will be responsible for the conference
program, finance, fundraising, communications, and logistics for this conference. With the intention of
continuing to serve a wide and diverse international audience, the 2022 TKRC will be planned as a hybridized
scientific meeting which will allow for (a) in person, live presentations; (b) live streaming and asynchronous
access to content. Proposals for original research will be solicited in the form of oral and poster presentations,
panel discussions, as well as breakout sessions. All submissions will undergo a blind peer-review process by 2
subject matter experts for quality, timeliness, and fit with the overall program, by the Scientific Review
Committee to be composed of researchers from Harvard, the TKC and additional subject matter experts.
The 2022 TKRC will include the request for teaching kitchen recipes, videos of demonstrations; and, case
studies summarizing personal success stories relating to the impact of teaching kitchen training on individuals,
families and/or organizations. Awards will be presented for the best scientific abstracts, best novel recipe/video
and best case-study summary. Special solicitations for culturally diverse programmatic and recipe content will
help offer a variety of content for all participant audiences.

Public health relevance
PROJECT NARRATIVE The covid pandemic accentuated the need for innovative lifestyle modification strategies whereby individuals learn- and maintain-self-care skills to improve the ways they eat, move and think in order to reduce their cardiovascular risk, and manage their chronic medical conditions, (e.g. overweight, obesity, pre-diabetes, diabetes, etc.). Teaching kitchen programs typically include multi-faceted approaches involving: (1) nutrition education; (2) culinary (aka cooking) instruction; (3) movement and exercise prescription; (4) training in mindfulness; and (5) strategies to promote health promoting behavior change. Research in this area may generate new knowledge, enhance health, lengthen life, and reduce illness and disability for a range of populations, including those experiencing food and nutritional insecurity; those confronting health disparities; and those at highest cardiovascular risk.